Using Administrative and Research Data to Investigate Risk and Protective Factors for Smoking During Pregnancy

PROJECT SUMMARY: This research uses cigarette smoking during pregnancy (SDP) for investigating risk-
processes in addiction. While population-level trends on sociodemographic risk factors for SDP and the
adverse effects on offspring associated with maternal SDP are well established, the more complex task of
understanding individual risk-prediction and its clinical application remains incomplete. I will implement a “big
data” approach using cross-linked research data (from a large female twin cohort, followed prospectively from
median age 15; new data collection with Native American mothers) and state individual-level vital and driving
records data (SDP, sociodemographics, geocoordinates) to characterize the interplay between individual and
environmental factors conferring risk or protection for continued smoking throughout pregnancy.
AIMS: (1.1) characterize interplay of sociodemographic and neighborhood influences on SDP using state data
on 100,000s of births, and examine potential confounders of racial disparities in SDP; (1.2) use cross-linked
research and state data to characterize effects of individual risk-factors (nicotine dependence, psychiatric and
trauma history) as predictors of SDP, including their interplay with a summary neighborhood/sociodemographic
risk-score derived from in (1.1); and cross-validate birth record SDP report; and (2) ascertain from state vital
records a new cohort of American Indian (AI) mothers (a cohort with very high rates of SDP) for a pilot
retrospective study, to extend findings in 1.2 to an understudied group and to address limitations of existing
research’s failure to identify specific cultural factors associated with SDP in this group.
METHODS: State birth record/driver’s license data (SDP, teen births, DUIs), aggregated to the census tract,
will be used for prediction of SDP risk, separately for mother’s residence during teen years and at time of
pregnancy, to supplement standard Census/American Community Survey socioeconomic disadvantage
predictors. Logistic regression will be used in (1.1) to generate a summary risk score for analyses with
research data in (1.2), reducing the risk of false-positive findings. Standard assessments optimized for use with
AI populations will be used in retrospective interviews of a small series of AI women.
PREDICTED RESULTS: Demonstration of race-specific interactive contributions to SDP risk of individual,
sociocultural, sociodemographic, and neighborhood characteristics, allowing tailored individual risk prediction.
CANDIDATE, TRAINING: The applicant is an MD-PhD candidate at a leading institution for training
successful independent physician-scientists, working with a strongly committed mentoring team, and using
unique resources. The proposed training plan provides new conceptual and technical training with an outlined
set of career development activities, workshops, and formal didactic opportunities, to support development as
an independent physician-scientist working to improve understanding, assessment, and treatment of addiction,
particularly in understudied/underserved groups.

Public health relevance
PROJECT NARRATIVE While population-level trends on sociodemographic risk factors for smoking during pregnancy and outcomes for offspring exposed to maternal smoking during pregnancy are well established, the more complex task of understanding individual risk-prediction, including for U.S. minorities, and its clinical application remains incomplete. Characterizing the relative influence of environmental and individual characteristics as risk or protective factors for continued smoking during pregnancy is a necessary next step for informing individual- and public health-level interventions to produce successful smoking cessation prior to pregnancy. Achieving smoking cessation prior to fist pregnancy would substantially reduce smoking-related mortality in child-bearing people.